Copper as a Photocatalyst: Applications in Decarboxylative Fluorination

PROJECT SUMMARY
Fluorination of pharmaceutical compounds has been shown to increase their potency through
modulation of their lipophilicity, acidity, and conformational bias. Photoredox decarboxylative
fluorination in particular has been recognized as a powerful strategy for accessing fluorinated
compounds. However, these methods have typically been limited to cooperative catalysis with
expensive Ir or organic photocatalysts. The Yoon lab has recently demonstrated a novel way to promote
oxidative photochemical decarboxylation using simple CuII salts. Irradiation of the CuII carboxylate
results in ligand-to-metal charge transfer, which leads to rapid decarboxylation to generate the alkyl
radical. They applied this strategy towards the decarboxylative amination of benzylic carboxylic acids.
This proposal details the application of this strategy towards oxidative decarboxylative fluorination
and investigation of the reaction mechanism of this approach. In the first Aim, the photochemical
oxidative decarboxylative fluorination of alkyl carboxylic acids will be developed using stoichiometric
copper as both the terminal oxidant and decarboxylating agent. Both radical abstraction and
nucleophilic fluorination mechanisms will be probed. The second Aim focuses on the development of a
copper-catalyzed photochemical decarboxylative fluorination using Selectfluor as a source of fluorine
and as an oxidant to turn over the catalyst. Use of catalytic copper allows for tuning of light absorption
and copper complexation through ligand choice. UV-Vis will be used to identify ligands that form copper
complexes that absorb light in the visible region and are stable in the presence of excess carboxylate.
The reaction mechanism will be interrogated through quantum yield studies. Finally, upon development
of the stoichiometric and catalytic methods, the mechanism and identity of the active copper species in
solution will be investigated through UV-Vis, EPR, and computational studies as part of the third Aim.
Development of this strategy provides a complementary approach to existing methods for the
incorporation of fluorine in small molecules using simple, inexpensive reagents and affords mechanistic
insight into a novel method for photochemical oxidative decarboxylation.

Public health relevance
PROJECT NARRATIVE The development of novel, effective pharmaceutical compounds is a major public health concern in light of the rise of antibiotic resistance, the resilience of many types of cancers, and other key health issues. Addition of fluorine to biologically active molecules, such as drug candidates, can increase the effectiveness of these molecules by increasing their potency, enabling them to be more easily absorbed, and modulating how our bodies metabolize them. This research entails the invention of a novel, mild method for the installment of fluorine to key building blocks and the study of the mechanism of this chemistry.